Administrative Core

The Administrative Core (Core A) will continue to provide programmatic direction, evaluation of scientific
progress, facilitate interactions among investigators, and provide administrative support to the Program as a
whole. The Program consists of three individual projects (Projects 1-3), and three Cores; Core A, the
Proteomics and Lipoprotein Characterization Core (Core B), and the Atherosclerosis and Bioinformatics Core
(Core C). The Principal Investigator, Dr. Karin Bornfeldt, will continue as the Program Director.
The Administrative Core will be responsible for the day-to-day administrative and fiscal support, and will
provide financial reports and oversight of the three Projects and Cores B and C. Other functions of Core A
include organizing monthly lab meetings and an annual retreat to provide coordination and communication
within the Program, organizing peer review of trainees’ fellowship applications to promote their careers, and
maintaining a website for data sharing and communication within the Program Project and outside
investigators following the Data Management and Sharing Plan. A Program Project Management Committee
consisting of the Project Leaders will be responsible for planning and dealing with local issues. An Internal
Advisory Committee will evaluate the Program Project on an annual basis to assess progress and direction.
The Administrative Core will also be responsible for annual evaluation of the entire program by outside
consultants and by the External Review Committee.